Penn Roybal Center on Behavioral Economics and Health

Program Director/Principal Investigator (Last, First, Middle): VOLPP, Kevin G.
The goal of the proposed Roybal Center is to build on the substantial momentum we established in the
previous grant period to accelerate progress on multiple fronts: understanding mechanisms of behavior change
using approaches from behavioral economics (Thematic Area of Focus #1 for this Funding Opportunity
Announcement and the thematic focus of our Center); physical activity promotion (Thematic Area of Focus #2);
leveraging technology to promote healthy aging (Thematic Area of Focus #7) using the NIH-funded Penn Way
to Health platform; and increasing the sustainability and persistence of behavior change (Thematic Area of
Focus #6). We have chosen these priorities recognizing shifts in health care delivery financing towards risk-
bearing contracts and growing interest among employers and health plans in technology- and incentive-based
approaches to health improvement. Our Management and Administrative Core will provide infrastructure to
support research activities in behavioral economics and health at the University of Pennsylvania (UPENN) and
among affiliated faculty at other universities. The Pilot Core will nurture Stage 0 and Stage 1 pilots through the
NIH Stage Model with carefully designed pilots that advance to Stage 2 and larger-scale (Stages 3 and 4) field
studies and Stage 5 implementation and dissemination in conjunction with private and public sector
implementation partners. Specific aims are to:
1.) Facilitate and support research across the NIH Stage model that advances the translation of behavioral
economic concepts to improved health and health behaviors for older adults (NIH Stages 0-5);
2.) Cultivate testing of mechanisms of behavior change and early-stage feasibility pilots (Stages 0-I)
3.) Support testing of ideas with promise in Stage 1 that have potential to improve the health of large patient
populations in research and community settings (NIH Stages 2-4);
4.) Collaborate with external health care organizations to disseminate our findings and support the
implementation of effective interventions (NIH Stage 5).
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): VOLPP, Kevin G. The Roybal Center will conduct impactful research with the potential to significantly improve health. We will conduct experimental studies, elucidating mechanisms of behavior change from a behavioral economics perspective and facilitating translation of research findings into practice by testing ideas in settings where, if effective, they could be deployed at scale. Our studies will also leverage advances in technology to promote healthy aging with a focus on increasing physical activity through a combination of intervention approaches that help people form better habits and leverage social support mechanisms to reduce social isolation and create more sustained approaches to behavior change. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page